Partnerships for Biomedical Research in Arkansas

Project Summary/Abstract
The University of Arkansas for Medical Sciences (UAMS) Genomics Core Facility is an important resource for
faculty and students in Arkansas who are engaged in research that impacts human health. Replacing the
Illumina NextSeq 500 Next Generation Sequencing (NGS) system, which is now eight years old and heavily
utilized for small and medium sized projects, with the new NextSeq 2000 will improve services provided by the
UAMS Genomics Core Facility to all users. This purchase will allow for more advanced NGS capabilities at
significantly reduced prices due to the more advanced technology, reduced cost of NGS reagents and,
economies of scale associated with the NextSeq 2000. The confluence of advances in molecular biology,
biotechnology instrumentation, and computational science are revolutionizing our understanding of biological
basic science and human disease. Breakthroughs for new types of drugs and molecular diagnostics for cancer
and many other recalcitrant diseases are occurring at an unprecedented rate. This is evidenced by FDA new
drug and diagnostic approvals, including entire new therapeutic modalities for treating cancer (ie, Immune
Checkpoint Inhibitors). Biotechnology and genomics are reshaping the economy in the United States and the
world. The mission of the UAMS Genomics Core Facility is to provide investigators with convenient access at
affordable prices to the latest technologies for advanced molecular profiling of biological samples. Importantly,
this includes NGS-based studies, experiments, and assays. Services are provided to investigators at UAMS,
and other universities in Arkansas including faculty and students from primarily undergraduate institutions in
the Arkansas INBRE network. Services provided may be “all inclusive” and consist of advice and meeting(s)
concerning an investigators’ question (hypothesis) along with assistance and guidance for an experimental
design. Initial meetings are essential in order to manage new users’ expectations and foster their success.
Additional NGS service components include: i) sample preparation with QA/QC validation, ii) running the
sample on the NGS instrument and, iii) bioinformatics pipeline processing (data analysis). The UAMS
Genomics Core Facility is fully supported and supplemented by the UAMS Rockefeller Cancer Institute and the
College of Medicine. State-of-the-art genomic scientific instrumentation is essential to facilitate novel research
for faculty and students in Arkansas. Additionally, the goal of obtaining NCI Cancer Center Designation by
UAMS will also be strengthened.

Public health relevance
Project Narrative The University of Arkansas for Medical Sciences (UAMS) Genomics Core Facility is an important resource for faculty and students in Arkansas who are involved with cutting-edge biomedical research. Replacing the Illumina NextSeq 500 Next Generation Sequencing (NGS) system, which is now eight years old and heavily utilized with the new NextSeq 2000 will improve services provided by the UAMS Genomics Core Facility to all users. State-of-the-art genomic scientific instrumentation is essential to facilitate novel research for faculty and students in Arkansas and, the goal of obtaining NCI Cancer Center Designation by UAMS will also be strengthened.